MOSAIC: Mobile Surveillance for ARI and ILI in the Community

DESCRIPTION (provided by applicant): Acute respiratory infections (ARI) including influenza-like illness (ILI) can result in significant morbidity and mortality, direct medical expenses including outpatient visits and hospitalizations, and indirect costs due to lost work and school days. New population-based studies assessing the incidence and etiologies of ARI/ILI need to be conducted as ARI/ILI incidence and transmission as well as factors associated with ARI/ILI epidemiology have changed since previous population-based studies were conducted decades ago. Likewise, modern diagnostic techniques such as reverse transcription polymerase chain reaction (RT-PCR) expands the potential for greater knowledge regarding the epidemiology and etiology of viral ARI/ILIs; in previous historical studies in an estimated 75% of ARI/ILI-associate samples no virus was identified. Specific Aims: 1) Identify incidence of ARI and ILI in a representative population-based community sample; (2) Identify the etiology of these ARIs and ILIs; and (3) Assess individual and household factors associated with incidence and transmission of ARI/ILI. Secondary aims: (1) Assess differences in prevalence and etiology of ARI/ILI between this study's community population and those seeking acute care; and (2) Determine effectiveness of influenza vaccination on prevention of influenza illness in the study's community sample. Methods: Three hundred households will be followed for at least a year, maintaining a surveillance population of approximately 1000 individuals per year. Households will be identified by randomly sampling an existing cohort of households currently enrolled in a community-based survey study already recruited via a random, stratified sampling of households in the Washington Heights/Inwood area of Northern Manhattan. ARI/ILI surveillance will be conducted twice-weekly using text messaging with phone follow-up. Nasopharyngeal swabs will be obtained from ill household members and analyzed to identify ARI/ILI associated viruses via multiplex RT-PCR. Individual and household factors associated with ARI/ILI incidence and transmission will be assessed using general estimating equation regression models. Comparing this study's data with hospital data will assess differences in prevalence/etiology of ARI/ILI between community populations and those seeking acute care. Laboratory data will be combined with our pediatric/ adult immunization registry to determine seasonal influenza vaccine effectiveness against lab-confirmed influenza using a case-control analysis. Outcomes: The primary outcomes will be (1) incidence and prevalence of ARI/ILI; (2) etiologies of ARI/ILI; (3) factors associated with ARI/ILI incidence and transmission. Secondary outcomes will include (1) differences in the prevalence and etiology of ARI/ILI between community population and those seeking acute care; (2) influenza vaccine effectiveness in prevention of laboratory-confirmed influenza. If successful this project could provide important new information to help plan ARI/ILI interventions including new vaccines, vaccination strategies, and surveillance for viral pathogens, including future outbreaks.

Public health relevance
PUBLIC HEALTH RELEVANCE: This study will provide important information regarding the incidence, etiology and factors associated with acute respiratory illness (ARI) and influenza-like illness (ILI) in a community sample hopefully leading ultimately to better prevention and control. It will also allow a direct comparison between the etiology of viral infection in a community versus a hospital-based sample, as well as of ILI incidence in the community compared to those acutely seeking care, potentially providing important information for viral surveillance, including strategies for future outbreaks. Additionally, this project will allow the calculation of influenza vaccine effectiveness against laboratory-confirmed influenza in a community sample. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Acute respiratory infections (ARI), including influenza-like illnesses (ILI), can result in significant morbidity and mortality, increased outpatient visits and hospitalizations, and indirect costs from loss of school and work days.1-15 Previous population-based studies have assessed the epidemiology of ARI/ILI, but were conducted as long as 50 years ago.16-19 It is likely that the epidemiology of ARI/ILI has changed since that time as individual and household characteristics have changed.20-24 Moreover, in those studies, a viral pathogen could not be identified in over 75% of ARI/ILI samples.7 Today, modern viral diagnostic techniques such as reverse transcription polymerase chain reaction (RT-PCR) expand our ability to more accurately and completely describe the epidemiology of numerous viral pathogens associated with ARI/ILIs. However, many recent studies using these techniques have focused on one specific viral etiology or assessed ARI/ILI in specific populations, most often patients seeking medical care or hospitalized, rather than taking a broader look at multiple viral pathogens in a community-based sample.25-37 Therefore, a clear need remains to assess the burden of ARI/ILI in a community-based population including identifying the etiology and risk factors for ARI/ILI and transmission. This may be particularly important in low-income communities whose members are at high risk for infection and transmission due to crowded living conditions and who may have decreased access to care.38-39 This study's purpose is to follow a sample of 300 households (approximately 1000 individuals) representative of an urban, underserved community and identify the incidence, etiology and risk factors associated with ARI/ILI using molecular diagnostic strategies to detect a wide variety of respiratory viral pathogens. We will also capitalize on existing resources to assess potential differences in ILI incidence in this community sample vs. emergency department surveillance data and etiology of ARI/ILI in community- vs. hospital-based samples, as well as to assess influenza vaccine effectiveness against lab-confirmed influenza. Aim 1: Determine incidence of ARI and ILI in a representative population-based community sample Three hundred households will be followed individually for 1-4 years, with replacement as necessary, to maintain a surveillance population of approximately 1000 individuals. Potential households will be identified by randomly sampling an existing cohort of households currently enrolled in a community-based survey study already recruited via stratified random sampling of households in the Washington Heights/Inwood area of Northern Manhattan. Once enrolled, households will receive text messages twice weekly to identify household members with symptoms meeting study case definitions for ARI or ILI. A bilingual research worker will obtain a nasopharyngeal (NP) swab in symptomatic individuals. Monthly home visits will also be made to facilitate retention and update information regarding household demographics and health status. Incidence of ARI and ILI as well as prevalence (as an estimate of disease burden) will be determined overall and stratified by age. Aim 2: Identify the etiology of ARI and ILI in a population-based community sample NP swabs will be analyzed to identify potential viral etiologies via multiplex RT-PCR using the FDA-approved FilmArray Respiratory Panel from Idaho Technologies, Inc. We will use a research panel that, in addition to the more common viral pathogens, also detects rarer subtypes of coronavirus, bocavirus, as well as three bacterial pathogens-Mycoplasma pneumoniae, Chlamydia pneumoniae and Bortadella pertussis. The incidence of specific pathogens and co-infection associated with ARI/ILI will be determined overall and by age. Aim 3: Assess individual and household factors associated with incidence and transmission of ARI/ILI We will use generalized estimating equations (GEE) to model the effects of individual and household factors, from survey data, associated with infection and transmission of ARI/ILI. Individual level factors will include factors such as sociodemographics, presence of chronic medical illnesses, and outside exposures such as work, school or daycare. Household level factors include factors such as household density and composition. Secondary Aim 1: Assess differences in epidemiology of ARI/ILI in community study population vs. those seeking acute care Etiologies of ARI and ILI overall and by age in the community-based sample will be compared to hospital data obtained from patients with ARI/ILI presenting to the emergency departments of the three Columbia University Medical Center (CUMC) hospitals that serve the population recruited for this study. The hospital laboratory serving these sites uses the same multiplex RT-PCR platform that will be used in this study. The incidence of ILI from the community sample will also be compared to NYS Department of Health syndromic surveillance data obtained from the Health Emergency Response Data System (HERDS). Secondary Aim 2: Determine influenza vaccine effectiveness against laboratory confirmed influenza Laboratory data from this study will be combined with our pediatric and adult immunization registry to determine effectiveness of seasonal influenza vaccination in preventing laboratory-confirmed influenza. Effectiveness will be determined overall as well as stratified by age and chronic medical conditions associated with higher risk for ARI or ILI-related morbidity/mortality, as appropriate.